Joint decomposition of SCORCH mulit-omic data to explore the impact of SUD and HIV on reward circuitry and neuroinflammation

Project Summary
Researchers around the world have produced hundreds of multi-omic datasets relevant to the
effects of substance use disorders (SUD) and Human Immunodeficiency Virus (HIV) in the
brain, and the volume of high-quality data continues to grow exponentially. Combined analyses
of these data are needed to fully harness their potential to discover biological mechanisms and
therapeutic targets, yet several barriers impede such efforts: (1) The data are spread across
many different repositories and have been processed in incompatible ways; (2) Standard
statistical frameworks are neither scalable enough nor flexible enough for this purpose; and (3)
Biologists and clinicians with limited bioinformatics skills are unable to directly interact with the
data or analytical results. Here, we propose an ambitious effort to overcome these barriers,
conduct a joint analysis of hundreds of multi-omic datasets related to SUD and HIV, and
democratize access for the entire research community. We will begin by assembling a
comprehensive resource of harmonized multi-omic datasets related to SUD and HIV, combining
datasets produced by the SCORCH consortium with hundreds of additional datasets profiling
the transcriptomes and epigenomes of single-cells, spatial positions, sorted neurons and glia,
and bulk tissues from the brains of humans, non-human primates, and rodents. Next, we will
perform joint analyses across this entire data compendium using newly developed joint
decomposition and transfer learning techniques to identify molecular signatures of SUD and
HIV. Our approach is uniquely suited to combine large numbers of heterogeneous datasets and
to prioritize specific genes and biological mechanisms for experimental follow-up. We will create
a biologist-friendly, web-based data visualization and analysis portal, leveraging the existing
NeMO Analytics platform. We will extend NeMO Analytics to include hundreds of multi-omic
datasets related to SUD and HIV, as well as by creating an application programming interface
so that computational biologists can access the resource for analyses in R and Python.
Collectively, our project will lead to a holistic understanding of the molecular effects of SUD and
HIV in the brain and resources that are findable, accessible, interoperable, and reusable for the
entire research community.

Public health relevance
Project Narrative We will establish a SUD / HIV focused data ecosystem with SCORCH data as its foundation and expand the collection to include historical, current and future relevant non-SCORCH datasets. We will use joint decomposition and projection tools of our design to identify characteristic biological signatures of SUD/addiction and HIV in the brains of non-human models to dissect compound signals in human patients with varied genetic and medical backgrounds. These harmonized datasets and signatures of addiction / HIV will be made available to the greater neuroscience community through NeMO Analytics, which will act as a genomics analysis hub for the field.